Cross-species conservation of inhibitory cell type contributions to visual cortical function

Project Summary
The function of the nervous system is dependent on complex interactions between networks of neurons
composed of multiple neuron types. Understanding how these networks function both in health and disease is
dependent on understanding the precise connectivity between specific neuron types and their functional
interactions in the intact brain. It is therefore apparent that, in order to have an adequate understanding of the
nervous system, it is necessary to have detailed descriptions of neuronal connectivity with the same level of
precision at which these systems operate and to selectively manipulate and measure the activity of specific cell
types in the context of the normal functioning network. Such studies would be greatly facilitated by the ability to
target gene expression to specific cell types in the context of AAV vectors. The aims of this proposal are
designed to first test and overcome possible limitations in the use of AAV vectors targeting gene expression to
SST- and PV-expressing inhibitory internueon in the visual cortex, and then to use these tools to selectively
manipulate the activity and characterize the functions of these inhibitory subclasses. The establishment of the
utility of these reagents will allow future studies testing the functional contributions of specific inhibitory neuron
types to perception,cognition and behavior.

Public health relevance
Project Narrative Understanding the detailed organization of cortical circuits involving specific neuron types is necessary to obtain a mechanistic understanding of the function of the cerebral cortex. Understanding the specific roles of genetically accessed neuron types in cortical function has important implications for human health, as these cell types and their activities are implicated in the cortical mechanisms that regulate attention and their disruption is implicated in schizophrenia and autism.